Chaplain Family Project Multicenter RCT

ABSTRACT
ICU admission is a major life crisis that can result in severe distress for the patient's family, both during and
after the hospitalization. This includes psychological distress such as anxiety and posttraumatic stress and also
spiritual distress, including crises of meaning, purpose, or religious faith. Facing life and death decisions as the
surrogate decision maker or experiencing the patient's death further increases distress. Prior interventions to
support ICU surrogate decision makers have affected end of life care such as ICU length of stay for patients
who die during hospitalization, but few have impacted surrogate well-being. We propose that for an ICU
intervention to improve surrogate well-being, it must provide intensive spiritual and psychological support.
Healthcare chaplains are highly trained professionals who provide spiritual and emotional support to patients
and family members of all faiths and those with no faith affiliation in the healthcare setting. Chaplains are
trained to listen deeply to an individual's religious and cultural experiences, providing opportunities to improve
the care of marginalized groups who have faced discrimination in healthcare. Connecting religious or spiritual
concerns and medical decisions also is a chaplain's skill. Although chaplains are part of the healthcare team in
many US ICU's, research about the outcomes associated with chaplains' spiritual care is just emerging, and
nearly all available randomized trials examined the effects of chaplains on patient outcomes. To address the
need for interventions that reduce surrogate distress, our team has developed the Spiritual Care Assessment
and Intervention (SCAI) Framework, an intervention for ICU surrogates that is rigorous, reproducible and
consistent with spiritual care standards of practice. Our prior, single site randomized trial of the SCAI
framework in the ICU demonstrated improved spiritual and psychological well-being for ICU surrogates in the
intervention group, but the study population lacked religious and ethnic diversity. We now propose an NIH
Stage 3 multi-center, randomized, attention controlled clinical trial of the SCAI Framework for surrogates to
evaluate efficacy in a sample with geographic, religious, racial and ethnic diversity. The study will take place in
6 geographically diverse sites that are also diverse in terms of religion, race and ethnicity. The intervention will
be delivered by skilled and highly trained chaplains. Specific aims are: to demonstrate the effects of chaplain-
delivered spiritual care on psychological and spiritual outcomes including anxiety, distress, spiritual well-being,
posttraumatic stress symptoms and complicated grief; to demonstrate the impact of chaplain-delivered spiritual
care on medical decision making; and to examine the effects of spiritual care among historically underserved
racial and religious subgroups. Results will guide hospital leaders, policy makers and the healthcare team
regarding chaplains' role in improving surrogates' psychological and spiritual health and the quality of decisions
for critically ill patients.

Public health relevance
NARRATIVE Given that there are over 5 million annual ICU admissions in the US, family distress represents an important public health concern. ICU admission is more common as patients age but may be especially traumatic when the patient is young or healthy, making life course an important factor in decision making for the patient and outcomes for the family. This study will provide information about the role chaplains can play in improving the well-being of family members in the ICU setting and can lead to policy recommendations and reimbursement for improving the psychological and spiritual well-being of ICU family members.